The effects of maternal borderline personality disorder on toddler theory of mind development

PROJECT SUMMARY/ABSTRACT
Theory of mind (ToM) is the ability to perceive and understand mental states in others a nd represents one
operationalization of the RDoC construct of Perception and Understanding of Others. ToM is an early emerging
mechanism in the development of borderline personality disorder (BPD); individuals with BPD tend to
misattribute mental states to others, spurring a cycle of anger dysregulation, interpersonal dysfunction, and
suicidal behavior. Aligned with the 2020 NIMH strategic plan, to identify malleable targets for prevention of BPD,
it is necessary to study the unfolding of this critical mechanism prior to the onset of symptomatology. The current
proposal aims to do so in a high-risk mother-child sample in which mothers have BPD and offspring are 36-48
months old, a critical time for ToM development. Further, this study will elucidate the specific behaviors that
mothers with BPD engage in that influence the development of ToM during the preschool period as well as child
behaviors involved in this process. ToM undergoes rapid development during the preschool age and is highly
susceptible to environmental influence, particularly interactions with caregivers. This proposal details a
comprehensive training plan that will enable me to address these questions while building on previous
experiences in important ways. First, expanding on my experience studying ToM and related processes in
adolescence, I will focus on the developmental trajectory of this construct during the preschool age. Second, I
will obtain training in measurement and interpretation of heart rate and RSA as physiological markers of
preschooler social engagement with mothers. Third, building on my knowledge of global behavioral coding of
mother-adolescent interactions, I will master the use of micro-analytic coding to obtain continuous time-series
data of mother and child behavior within interactions. Further, I will learn novel analytic methods for this unique
data based on dynamic systems modeling. The specific aims of this study are to 1) Determine whether two forms
of maladaptive maternal behaviors--hostility and inaccurate mental state attribution--are observed more often
among mothers with BPD compared to those with no psychiatric disorder; 2) Evaluate how preschooler social
engagement with mothers (i.e., approach and withdrawal behaviors as well as heart rate and RSA) is influenced
by these maternal behaviors; and 3) Test the effect of identified maternal behaviors on the trajectory of ToM
development over the course of one year in preschoolers. The central hypothesis of this proposal is that maternal
BPD is associated with maladaptive behaviors directed toward their children. These behaviors lead to a pattern
of dysfunctional social engagement by preschoolers (decreased approach and increased withdrawal behavior
toward mother during as well as heart rate deceleration and RSA withdrawal), which further inhibits their ToM
development during this critical phase. By identifying risk factors associated with ToM, families at risk can be
targeted for specific interventions focused on improving the quality of mother-child interactions, which may have
the effect of preventing BPD onset in offspring.

Public health relevance
PROJECT NARRATIVE Theory of mind, or the ability to attribute mental states to others, is an early emerging, core mechanism involved with the development of borderline personality disorder and is substantially influenced by maternal interactions in early childhood. In line with NIMH’s strategic aims to determine early risk factors and related mechanisms to serve as novel intervention targets, this proposal seeks to test how mothers with borderline personality disorder influence the trajectory of theory of mind development in their preschool children. By testing the role of specific mechanisms (maternal behaviors, child response to these behaviors) for theory of mind development, this proposal has the potential to reveal targets among high risk mother-child dyads that can alter risk trajectories for borderline personality disorder and thus strengthen prevention efforts; furthermore, this study can provide critical information about the unfolding of risk mechanisms for borderline personality disorder.